Improving the Processes around Approval, Accrual and Translational Research in Cancer Prevention Trials

ABSTRACT
The central goal of this R50 Clinician Scientist Award application is to establish and refine processes that
facilitate clinical trials in cancer interception at The University of Kansas Cancer Center (KUCC), a unique
goal that is different from the majority of R50 applicants which focus on cancer treatment trials. Cancer
prevention⎯renamed cancer interception, i.e., active rather than passive cancer prevention to disrupt cancer
pathways early⎯is an NCI priority. The KUCC NCI-designated comprehensive cancer center is the regional
leader for oncology care and its Cancer Prevention and Control (CPC) research program reorganized in 2019
has already had tremendous success; 69% of CPC members are principal investigators on funded cancer-
related research grants, including 29% funded by the NCI. CPC members published 309 articles in 2022. I am a
gastroenterologist and a physician-scientist with a focus on cancer prevention/interception. I joined KUCC in
2017 to build our gastrointestinal (GI) cancer prevention program, a major regional need, from ground up. The
program has grown exponentially and now also serves as a conduit for accrual into cancer prevention, biomarker,
and imaging trials. One such example is the 14-center NCI trial, “A Phase II Clinical Trial of the Multitargeted
Recombinant Adenovirus 5 (CEA/MUC1/Brachyury) Vaccine (Tri-Ad5) in Lynch Syndrome (NCT05419011)”
where I serve as the Lead PI and Study Chair. The KUCC Clinical Trials Office (CTO) has successfully supported
cancer treatment trials, however many of the CTO’s processes for cancer interception trials can still be improved.
Cancer interception trials have different challenges compared with cancer treatment trials because the patient
population does not have active cancer and therefore does not interact directly with the cancer centers. Unlike
treatment trials, these cancer prevention participants may not experience immediate benefits. Hence, the
recruitment and retention strategy will need to be embedded within the clinical care structure which provides
immediate value: the central idea behind my GI cancer prevention program. I propose to improve the KUCC
CTO’s processes by: i) hiring project navigators to facilitate study approvals for the PIs in non-oncology
departments, outside KUCC; ii) training research coordinators in prevention trials; iii) establishing processes for
resource sharing between KUCC and non-oncology departments; iv) streamlining analysis of translational
endpoints; v) improving minority recruitment via Juntos, a homegrown center to promote Latino health; and, vi)
expanding the existing, “The Kansas Patients and Providers Engaged in Prevention Research (KPPEPR)
Network” to improve access of underserved rural populations to cancer prevention trials. I will use my active
participation in two NCI-supported Early Phase Clinical Cancer Prevention Consortia (Northwestern University
and University of Michigan) to bring cancer prevention trials to KUCC and train junior faculty members to sustain
the growth of this program. I have established relationships with leading investigators in the field to develop new
research capabilities such as messenger RNA cancer vaccines for cancer interception.

Public health relevance
Project Narrative The Clinical Trials Offices (CTO) at many cancer centers focus on cancer treatment trials but not on cancer prevention trials that target high-risk populations but without active cancers. Establishing and refining current processes around CTO’s cancer prevention trials could bolster NCI’s efforts at cancer prevention.